2023 RNA Editing Gordon Research Conference and Gordon Research Seminar

Project Summary
The GRC on RNA editing is the premier international meeting dedicated to nucleic acid modifications. The
2023 meeting is subtitled: “RNA/DNA editing and epitranscriptomics across biological systems”. Modifications
to the common nucleosides found in DNA and RNA have been known for many years. However, recent
advances in analytical techniques for their detection, along with a deeper understanding of the broad impact
these modifications have on fundamental biological processes, including human disease, have caused a
renaissance in their study. Indeed, we now know that nucleic acid modifications are common in various
naturally occurring nucleic acids and influence gene expression, protein synthesis, cognition, innate and
adaptive immunity, autoimmune disease and cancer. Furthermore, several research labs have repurposed
enzymes that naturally edit RNA or modify DNA bases for targeted genome editing. This meeting will bring
together a diverse group of scientists with varying expertise with the common goal of sharing ideas and
approaches that can advance our understanding of the many facets of nucleic acid modifications. This
conference has three specific aims. First, we will support the development of the next generation of scientific
leaders. Key to achieving this aim is supporting the accompanying Gordon Research Seminar (GRS). In the
two days preceding the GRC, a GRS will take place that is focused on the exchange of research data and
ideas among graduate students and post-docs in the editing and modification field. Our second specific aim is
to facilitate knowledge exchange on DNA and RNA editing and modification. During the five day GRC, there is
approximately four hours in each afternoon for networking, there are four poster sessions, 46 speakers and 6
speakers selected from abstracts covering all aspects of DNA and RNA editing research to foster
interdisciplinary and collaborative interactions. Our third aim is to connect academic researchers to
stakeholders in industry. Representatives of gene editing companies and biomedical science companies with
an editing/modification focus will participate in the 2023 conference. This interaction will facilitate collaboration
with companies or other labs that can take basic health related research to the next level of developing
treatments for genetic diseases.

Public health relevance
Project Narrative The Gordon Research Conference on RNA editing 2023 is subtitled: “RNA/DNA editing and epitranscriptomics across biological systems” and is the premier international meeting dedicated to nucleic acid modifications. This meeting will bring together a diverse group of scientists with varying expertise with the common goal of sharing ideas and approaches that can advance our understanding of the many facets of nucleic acid modifications. This type of meeting is necessary to achieve the goal of taking basic health related research to the next level of developing treatments for human disease.